Continued Support and Development of SBML

DESCRIPTION (provided by applicant): Molecular biologists are increasingly realizing that computational modeling of sub-cellular mechanisms is crucial for making sense of human biology and advancing medical research in the context of the vast quantities of complex experimental data that are now being collected. The biology community needs agreed-upon information standards if models are to be shared, evaluated and developed co-operatively. The Systems Biology Markup Language (SBML) is becoming a de facto standard exchange format for representing formal qualitative and quantitative models of systems of biochemical reactions. The long-term objectives of this proposal are to support and further develop SBML and related software infrastructure for the benefit of the computational biology community. The specific aims are the following: 1. Work with the community of software developers and users to (a) continue evolving SBML and extending the language into SBML Level 3 with features developers have been requesting, and (b) formalize the SBML language development process and transfer its control to the community. 2. Maintain and extend existing software libraries for working with SBML with facilities for (a) reading and writing SBML Level 3, (b) reading model definitions in other formats including CelIML, and (c) transforming model definitions into other formats such as CelIML, MATLAB, Mathematica, HTML, and others. 3. Produce documentation, including a "best practices" guide to working with SBML, and performing training functions to help educate software developers and modelers in the use of SBML and the software tools available for working with the language.